Tech-enabled Functional Health: Bridging Primary Care Gaps for Older Adults with Functional Disabilities

Project summary
Functional disabilities (FDs), defined as difficulties in performing daily activities, constitute a significant public
health problem associated with increased dependency, poor health outcomes, diminished quality of life,
institutionalization, and premature death. Older Latinos residing in Puerto Rico (PR) are disproportionately
affected by FDs, with one of the highest rates of FDs (58%) in the US and its territories. Research has
demonstrated positive outcomes from employing assistive technology (AT) devices, such as jar openers, sock
aids, and canes, among older adults with FDs, thereby enhancing their functioning, participation, and capacity
to remain at home or in the community for longer. However, Latinos are among the least likely to utilize AT.
Given the dearth of culturally competent assistive technology interventions for Latinos, along with the scarcity of
rehabilitation professionals and assistive technology services in primary healthcare facilities, this project
leverages preliminary data from a prior study that assessed the feasibility of the 'Viviendo las Ventajas de la
Asistencia Tecnológica' (VIVE-AT for short; 'Living the Advantages of Assistive Technologies') intervention. The
specific aims of this project are to: 1) refine the protocol of the VIVE-AT to align with the unique needs of the
primary health care clinic; 2) assess the efficacy of the VIVE-AT in comparison to a waitlist control arm in
decreasing FDs and improving the quality of life among Latinos aged ≥65 years post-intervention and at six
months; and 3) evaluate whether proposed mechanisms of change in FDs, specifically knowledge of AT,
motivation for using AT, self-efficacy for using AT, and use of AT, account for the reduction in FDs post-
intervention. To achieve these aims, the interdisciplinary team of this project will first refine the intervention based
on recommendations from participants in the feasibility study and input from the Community Advisory Board and
older Latinos with FDs through iterative focus groups (Aim 1). Subsequently, 76 older Latinos with physical FDs
recruited from a primary health care facility serving low-income communities in PR will be randomly assigned to
either the VIVE-AT intervention group (n=38) or a waitlist + attention calls controlled condition group (n=38) to
assess its efficacy and mechanisms of change (Aims 2 & 3). All participants will receive standard usual care at
the primary health care center. Participants in the intervention group will attend a weekly, two-hour group session
for six weeks, facilitated by trained healthcare workers, focusing on self-management of FDs through AT.
Additionally, participants will receive up to five AT devices tailored to their specific FI needs and training on their
usage. All participants will be assessed at baseline, post-intervention, and six months after intervention. The
goals of the VIVE-AT are to encourage participants to use AT devices to self-manage their FDs and improve
their quality of life. Our approach will contribute to scientific knowledge and inform a subsequent scalable
multisite Hybrid Type I RCT designed to evaluate its effectiveness in reducing physical FDs among older Latinos
in primary healthcare settings in the U.S. and P.R.

Public health relevance
Narrative Many older adults experience physical disabilities that limit independence and increase healthcare needs. This project will test a group-based program in primary care that teaches older adults who live in their homes how to use assistive technologies to improve functioning in daily living activities and quality of life. If effective, the program could reduce disability, lower healthcare costs, and provide a scalable, evidence-based program to support healthy aging across the U.S. and Puerto Rico.